Spatiotemporal interrogation of metabolic cooperation between heterogenous lung cancer subpopulations in collective cell invasion

PROJECT SUMMARY/ABSTRACT
Not Requested

Public health relevance
PROJECT NARRATIVE Not Requested